Administrative Core

PROJECT SUMMARY/ABSTRACT - ADMINISTRATIVE CORE
The overall objective of the Administrative Core is to manage all pertinent administrative, financial, and
operational needs within the UCSF Prostate Cancer SPORE. The Core will oversee evaluation processes by
which each project and each element of the SPORE is assessed in regards to meeting its stated goals and the
overall translational research goals of the SPORE. The Administrative Core will achieve these objectives through
the following Specific Aims, which align with the requirements of PAR-20-305: 1: Leadership, 2: Administrative
Management, 3: Integration within SPORE and the Institution, 4: Cancer Patient Population, 5: Data
Management, and 6: Planning and Evaluation Activities. The Core will coordinate and integrate these aims
across the SPORE, ensuring program progression among all aspects, including Research Projects, Scientific
Cores, and the Developmental Research and Career Enhancement Programs. Felix Feng, MD and Eric Small,
MD, Principle Investigators of the UCSF Prostate Cancer SPORE, will co-lead the Administrative Core. Drs.
Feng and Small are highly productive investigators with a strong history of leadership in the institution and whose
complementary strengths will enhance the performance of the Core and the SPORE as a whole. The
Administrative Core will oversee overall program organization and fiscal oversight, as well as the developing
dynamic collaborations. Final review of all NCI reports will be conducted by the Core to ensure compliance with
university and federal policies. Drs. Feng and Small, by leveraging their corresponding strengths in basic and
clinical research, will be responsible for monitoring the overall scientific progression of the program and the
mentorship of trainees. This Administrative Core provides the framework to support the success of the UCSF
Prostate Cancer SPORE as a cohesive group of investigators, committed to supporting the development of
researchers and clinicians in the field of translational prostate cancer research.